Social Stress, Epigenetics and Cardiometabolic Health Among Youth

There is extensive evidence that economic and social stressors shape the development of cardiovascular disease starting early in the life course. However, it is largely unknown how social and economic stressors affect biological processes, particularly at the cellular level and whether these processes are evident among children and adolescents. Latinos, the largest and fastest growing ethnic minority group in the United States, have a high prevalence of cardiovascular risk factors and experience higher rates of poverty and social stressors in both childhood and adulthood compared to other racial/ethnic groups. One novel method to evaluate possible mechanisms underlying the associations between stressors and cardiovascular health across the life course is DNA methylation. Recently a handful of small studies have found that stressful experiences may alter DNA methylation, thus providing a potential mechanism by which social stressors may get under the skin. We propose to examine the association between social stressors, in relation to DNA methylation, mitochondrial DNA (mtDNA) damage and cardiometabolic health, among children participating in the Hispanic Community Health Study /Study of Latinos (HCHS/SOL) Youth Study. The HCHS/SOL Youth study is a study of US Latinos, representing varied countries of origin, conducted in the US. We propose to use existing data from 1200 participants who completed the HCH/SOL Youth study and who provided blood samples. Existing blood samples will be assayed for DNA methylation age, genome-wide methylation and a mtDNA damage marker. Cardiometabolic health markers (obesity, diabetes, hypertension, inflammation and lipids) have also been assessed. Existing data also includes assessments of current family environment as well as socio-cultural factors among children. Specifically, we will examine 1) whether social and economic stressors are associated with DNA methylation age, mtDNA damage and genome-wide methylation; 2) whether DNA methylation age, genome-wide methylation and mtDNA damage is associated with cardiometabolic health among children and 3) whether socio-cultural factors (i.e, ethnic identity, parental closeness, place of birth) modify the association between social and economic stress and DNA methylation and mtDNA damage association. Completion of this project would allow us to elucidate the impact social and economic stressors have on epigenetic and cardiometabolic markers that may help explain how stress shapes persistent population health disparities among Latino populations.

Public health relevance
Social and economic stressors are increasingly recognized as important factors that shape the development of cardiovascular disease particularly among Latinos, who experience a disproportionate burden of of these factors across the life course. However, the pathways through which social and economic stressors affect the biological pathways related to health disparities are not fully understood, particularly at the cellular level, and little research to date has examined how these factors impact cardiovascular markers early in the life course. We propose to address these gaps by examining how social and economic stressors experienced in childhood impact DNA methylation (e.g. DNA methylation age, genome-wide methylation) and mtDNA damage, among a diverse sample of Latino youth living in the US, as well as how these factors may impact their cardiometabolic health.